Endothelial PHD2 in hypertensive vascular remodeling

Summary: Arterial stiffness is the center feature of hypertension and has significant impact upon disease
etiology and outcomes. So far, there is no cure for hypertensive arterial stiffness. Therefore, it is urgent
to identify potential therapeutic targets that can reduce hypertensive arterial stiffness. Emerging evidence
indicates that pericyte is a novel target of angiogenesis and vascular remodeling. Pericytes are a
subpopulation of mesenchymal stem cells which can differentiate into osteoblasts, vascular smooth
muscle cells (VSMCs) and fibroblasts. Pericytes promotes fibrosis formation via pericyte-(myo)-fibroblast
transition (PFT). Pericyte also has been shown to differentiate into VSMCs at arterial remodeling zones
in the heart. Our recent study found that deletion of oxygen sensor prolyl hydroxylase-2 (PHD2) in the
endothelium resulted in excessive pericyte recruitment and arterial stiffness, and exacerbation of
angiotensin II (Ang-II)-induced hypertension. Knockout of endothelial PHD2 caused an imbalanced
arginase-2/eNOS favoring in arginase-2. Furthermore, knockout of endothelial PHD2 significantly
increased osteogenic differentiation markers (SOX9, BMP2 and osteopontin) in the aorta and promoted
VSMC calcification. Using NG2 pericyte tracing reporter NG2DsRedBAC mice, our preliminary study
further suggested an important role of NG2+ pericyte in Ang-II mediating vascular remodeling. Based on
our findings, we hypothesize that deactivation of PHD2 in EC enhances arterial stiffness and
hypertension by the mechanisms involving an imbalanced arginase-2/eNOS and pericyte differentiation
into VSMCs, osteogenic cells and fibroblasts via HIF-2α-PFKFB3 signaling pathway. Two specific aims
will be proposed to test: Aim 1: To define the molecular mechanisms by which endothelial PHD2
regulates arterial stiffness with a focus on an imbalanced arginase-2/eNOS. We will determine: (i)
whether deficiency of endothelial PHD2 induces an imbalanced arginase-2/eNOS via HIF-2α-PFKFB3
signaling pathway, (ii) whether pharmacologic blockade of HIF-2α using a clinic relevant and highly
specific inhibitor PT2385 attenuates PFKFB3 expression, restores arginase-2/eNOS balances and
reduces Ang-II-induced arterial stiffness in PHD2ECKO mice; and (3) whether knockout of arginase-2
reduces vascular remodeling and arterial stiffness in PHD2ECKO mice. Aim 2: To define the role of PHD2-
PFKFB3 in mediating pericyte differentiation and hypertensive arterial stiffness. Using pericyte tracing
reporter NG2DsRedBAC (Tg) mice crossing with PHD2ECKO mice, we will test whether inhibition of
PFKFB3 attenuates osteogenic differentiation of pericytes, and reduces vascular calcification. We will
further determine whether pharmacological activation of PHD2 or inhibition of PFKFB3 attenuates Ang-
II-induced pericyte-fibroblast/VSMC transition, arterial stiffness and hypertensive vascular remodeling.
Our study has clinical translational significance for the understanding of pericytes in vascular stiffness.

Public health relevance
Narrative: The incidence of hypertensive cardiovascular remodeling and arterial stiffness is increasing at an alarming rate with no cure, it is therefore urgent to identify potential therapeutic targets that can reduce the high mortality rate of hypertensive cardiovascular remodeling and arterial stiffness. Emerging evidence suggests endothelial/pericyte interactions and NG2 pericytes may be novel targets for the treatment of hypertensive cardiovascular remodeling and vascular stiffness. The proposed studies will reveal how endothelial oxygen sensor PHD2 and glycolytic metabolic reprogramming regulate endothelial/pericyte interactions and NG2 pericyte recruitment in hypertensive vascular remodeling and arterial stiffness, and will create a new platform for drug discovery for hypertensive cardiovascular remodeling and vascular stiffness.